Antibiotic Prophylaxis to Prevent Obesity-related Induction Complications in Nulliparae at Term (APPOINT 2.0)

Project Summary/Abstract
Obesity increases the risk of pregnancy complications, including puerperal infections and cesarean delivery,
and risk rises with increasing body mass index (BMI). Since obese women are more likely to have
comorbidities that would necessitate delivery prior to their due date (i.e. prior to 40 weeks gestation), and class
III obesity specifically is an indication for delivery by 39 weeks, these patients have a high rate of labor
induction. In nulliparous women from the general population (obese and non-obese), labor induction at 39
weeks (compared to expectant management) is associated with less maternal morbidity and a lower cesarean
rate. We previously conducted a pilot randomized placebo-controlled trial in obese, nulliparous women
undergoing labor induction at term and found that the cesarean delivery rate was lower in women who received
a prophylactic antibiotic regimen during labor compared with those who received the placebo. Our proposed
multi-center trial aims to test this hypothesis in a large sample with adequate power to determine whether
prophylactic antibiotics during labor are associated with a decrease in the rate of cesarean delivery in term,
nulliparous, obese women. If the findings from the pilot trial are confirmed, this would represent a novel
intervention to decrease the cesarean delivery rate in a subset of women at highest risk for cesarean-related
complications.

Public health relevance
Project Narrative We previously conducted a pilot randomized placebo-controlled trial that found that the cesarean rate was lower in obese, nulliparous women who received prophylactic antibiotics during labor inductions. The currently proposed study is a multicenter trial evaluating the same intervention in that population. Should we have results similar to those in the pilot trial, prophylactic antibiotics for the indication of labor induction would represent a novel intervention to decrease the cesarean delivery rate in a group at high risk for that outcome